CORE--DEVELOPMENTAL FUNDS

Description: A total of $780,000 for Developmental Funds is requested in year 29. Of this amount, $440,000 is targeted for recruitment of new investigators. Each recruitment will provide $220,000 in faculty start-up funds for three years to be matched by institutional resources resulting in total packages in the range of $500,000. Over the five years of funding, six faculty members will be hired, two in the first year and one in each of the subsequent years. It should be noted that the support requested for recruitment will increase from $440,000 in year one to $660,000 in years 2, 4, and 5 and $880,000 in year 3. One hundred thirty thousand dollars are requested to support four laboratory pilot projects at $20,000 each and one clinical pilot project at $50,000. One hundred eighty thousand dollars are requested to develop two new shared resources. One will be a small molecule screening shared service and the other will be a tissue acquisition service. Finally, $30,000 are requested for interim support of investigators with lapses in peer-reviewed funding.